Low-level Arsenic Exposure and Cardiovascular Disease in Multi-Ethnic Adults (MESA As)

PROJECT SUMMARY
The parent grant, entitled “Low-level Arsenic Exposure and Cardiovascular Disease in Multi-Ethnic Adults
(MESA As)”, aims to investigate the cardiovascular effects of low-level arsenic (As) exposure in US adults of
multiple racial/ethnic groups. The Multi-Ethnic Study of Atherosclerosis (MESA) is a population-based study of
nearly 7,000 participants from 6 US cities, with known health outcomes over two decades. During the
measurement of urinary As species in the parent grant, we noticed that we could identify selenium (Se)
species during the same analytical run in which we measured As species. With support from a P30 pilot study,
we are validating those species in a subset of MESA urine samples. We propose to expand this pilot, and the
scope of the parent grant, to assess the extent to which low-level Se exposure is associated with
cardiovascular disease, by adding new data on Se species in urine to the parent grant. Selenium is an
essential element with a narrow safety range, meaning that both low and high intake can increase disease risk.
Humans mainly excrete Se through urine and urinary Se speciation is of particular interest for understanding
human bio-metabolism and Se-related health outcomes. Human urinary Se speciation can be influenced by
dietary Se intake and genetic variability and is dominated by selenosugars, trimethylselenonium ion, and
inorganic Se oxyanions. However, the individual influence of Se species on human health and disease remains
largely unexplored as it is rare for epidemiological studies to measure Se species in the urine. We plan to
augment our current analytical method in MESA, originally established for speciation of As in urine, for the
simultaneous determination of As and Se species in a single measurement. The availability of Se species in
urine will provide key data to examine the association of individual Se species and gene-Se species
interactions, rather than total Se only, on human health outcomes.

Public health relevance
PROJECT NARRATIVE Selenium is an essential element for the human body to stay healthy, but only when supply is adequate. We will expand our current analytical method used for speciation analysis of arsenic in urine, for the simultaneous determination of As and urinary Se species in a single analytical run. This study will provide key preliminary data in support of the first large study examining the effect of individual Se species and gene-Se species interactions, rather than total Se only, on cardiovascular health outcomes.